Induction of fibrotic lung injury by inhalation exposure to arsenic and arsenic-containing mine tailings

PROJECT SUMMARY (Project 2: Ding, Zhang)
Chronic environmental exposure to arsenic (As), the major toxic contaminant in mine tailings (mt), is associated
with increased incidence of lung diseases in humans, posing a severe health risk to people living near
contaminated sites. Populations residing near mining sites may be chronically exposed to toxic metal(loid)s via
the inhalation of dusts and ingestion of contaminated water or food, as the metal(loid)s in the dusts can become
bioaccessible. The toxic potential of inhaled As and other metal(loid)s in mine tailings particulate matters (mt-
PMs) is unclear, partly due to the lack of knowledge about their bioavailability in the target tissue following
inhalation exposure and of studies that associated toxicant levels and types with mt-PMs-induced lung toxicity.
Our goal is to discern the toxic potential of inhaled metal(loid)s in mt-PMs by studying toxicokinetics (TK) of the
metal(loid) contaminants in an inhalation exposure model of dust-induced lung injury and advance the
development of strategies and guidelines for risk detection and disease prevention. This goal and our objectives,
to characterize inhalation dust exposure, identify toxicity of individual metal(loid)s in mt-PMs, and test impact of
co-exposures to As and mold (fungal spores) on lung health, address the NIEHS SRP Mandates 1 and 2. The
potential for inhaled metal(loid)s to reach lung cells is high, as it precedes systemic metabolism and inhalation
is a major route for dust exposure. The TK differences between ingestion and inhalation, including differing
profiles of metal(loid) species in the lung, provide key rationale for studying the risks of lung injury from inhalation
of mt-PMs, particularly PM2.5s, which can accumulate in distal (smaller) airways. As ingestion induces lung
fibrosis in rats and mice and As exposure is associated with increased incidence of lung fibrosis in humans.
Thus, we will use As-induced fibrotic lung injury as a model to characterize the ability of inhaled As-containing
dusts (ACDs) to induce lung injuries and gain insights into the inhalation TK of dust-associated toxic metal(loid)s.
Aim 1 hypotheses are: 1) inhaled ACDs are more effective than ingested As in the induction of fibrotic lung
injury; 2) inhaled As5+ is more potent than inhaled dimethylarsinic acid (DMA); and 3) co-exposure to fungal
spores will exacerbate inhaled ACDs’ toxicity. Aim 2 hypotheses are: 1) greater portions of inhaled As are
available to lung cells as As5+ or As3+ rather than DMA, compared to that of ingested As; 2) inhaled As is enriched
in distal airways and lung parenchyma; and 3) As ingestion, through inhibition of mucociliary clearance, leads to
increased dust persistence in the lung and higher inorganic As levels from ACDs inhalation. Aim 3 will determine
the ability of inhaled mt-PMs found in Superfund sites and neighboring communities to induce fibrotic lung injury
and identify major non-As metal(loid)s responsible for the toxicity of mt-PMs.

Public health relevance
PROJECT NARRATIVE (Project 2: Ding, Zhang) Chronic environmental exposure to As metal(loid)s, the major toxic contaminants in mine tailings, is associated with increased incidence of lung diseases and populations residing near Superfund mining sites may be chronically exposed via inhalation to not only toxic metal(loid)s but also fungal spores. The toxic potential of inhaled metal(loid)s in mine tailings particulate matters is unclear, and the combined health risks to lung function and disease from metal(loid)s and fungal exposures are unexamined. The proposed studies will enable the establishment of a mechanistic model of how chronic exposure to dust that is co-contaminated with metal(loid)s and fungal spores contributes to the development of nonmalignant lung diseases, particularly lung fibrosis, and provide pivotal mechanistic data for developing strategies and guidelines for risk detection and disease prevention in communities neighboring mine waste sites.